Therapeutic Mitochondrial Uncouplers

PROJECT SUMMARY
The goal of this project is to develop small molecule mitochondrial uncouplers for the treatment of non-
alcoholic steatohepatitis (NASH), an advanced form of non-alcoholic fatty liver disease (NAFLD). Approximately
26 million people (~6-8% of US population) are affected by NASH, and more than 30% of patients with NASH-
related cirrhosis will die from liver failure or hepatocellular cancer. There are currently no FDA-approved drugs
to treat NASH and the top drugs in clinical trials suffer from ineffectiveness or have unwanted side effects. NASH
is characterized by fat accumulation in the liver, inflammation, and tissue remodeling. Mitochondrial uncouplers
have strong potential as NASH therapeutics by the nature of their mode of action targeting fat accumulation and
oxidative stress. Mitochondrial uncouplers transport protons from the mitochondrial intermembrane space into
the matrix bypassing ATP synthase. This process increases fat oxidation and decreases mitochondrial reactive
oxygen species production; thereby, directly targeting two pathways that underlie NASH pathophysiology that
drive inflammation and the fibrogenic response. Our laboratories have recently discovered mitochondria-
selective, safe, and orally bioavailable mitochondrial uncouplers that have wide therapeutic window. Proof-of-
principle studies in an accelerated mouse model of NASH (STAM model) achieved the FDA benchmark for
approval of a NASH therapeutic by decreasing the NAFLD Activity Score (NAS) by 2 points, with at least one
point coming from two different NAS criteria, and with no worsening of fibrosis. These strong preliminary data
support a medicinal chemistry program to improve the drug-like properties of the molecules (Aim 1) and validate
molecules in a more physiologically and clinically relevant mouse model of NASH involving Amylin diet (Aim 2).
The major innovation of our program is the discovery of novel chemical scaffolds that have different levels of
mitochondrial uncoupling capacity that are safe and self-limiting. As there are currently no drugs with a
mitochondrial uncoupling as the primary mode of action in the clinic, our program could be the first to deliver
mitochondrial uncouplers for the treatment of NASH. Indeed, this project addresses a critical need and will make
significant contribution to data supporting the validity of modulating mitochondrial uncoupling for safe and
efficacious treatment of NASH.

Public health relevance
PROJECT NARRATIVE In this project, we will develop novel small molecule mitochondrial uncouplers as therapeutics for the treatment of non-alcoholic steatohepatitis (NASH), a type of fatty liver disease. Key features of these compounds are their selectivity for mitochondria and safety by virtue of their self-limiting properties.